mAnaging siCkle CELl disease through incReased AdopTion of hydroxyurEa in Nigeria (ACCELERATE)

Project Summary/Abstract
Large knowledge gaps remain regarding strategies to promote the adoption of hydroxyurea (HU), particularly in
sub-Saharan African countries including Nigeria, where more than 75% of annual sickle cell anemia births occur.
The vast majority of people with SCD in Africa do not receive evidenced-based health care (e.g., newborn
screening, health education, prophylaxis for infection, optimal nutrition and hydration, blood transfusion,
transcranial Doppler screening, and HU therapy), despite its effectiveness in reducing SCD-related adverse
outcomes and mortality. The use of HU in SSA is <1% among SCD patients. Our preliminary findings indicate
that provider-level barriers are significant and must be addressed to improve HU adoption. To address HU
adoption we will use the NIH-funded study (e.g., Realizing Effectiveness Across Continents with Hydroxyurea
(REACH) Clinical Trial (NCT01966731)) that developed an evidence-informed, clinical, practical, and easy-to-
follow algorithm to 1) Screen patients for sickle cell disease (SCD), 2) Initiate HU treatment, and 3) Maintain HU
dosage over time (SIM) for the improved management of SCD as our intervention. The Nigerian government
released guidelines supporting the SIM intervention for HU adoption for improved SCD management, and HU is
on the list of essential medicines for Nigeria. Our implementation strategy for improving SCD management in
Nigeria uses a practical and replicable evidence-based task-sharing strategy, TAsk-Strengthening Strategy for
Hemoglobinopathies (TASSH), adopted from our TAsk-Strengthening Strategy for Hypertension control
(TASSH) trials in Ghana and Nigeria containing the essential components of i) Training healthcare
workers/providers to be more patient-centered in clinical consultations, ii) Clinical reminders, and iii) Practice
facilitation (TCP) known as (TASSH TCP) for SCD management. Using a sequential exploratory mixed-methods
study design, we will conduct this study using the Exploration, Preparation, Implementation, and Sustainment
(EPIS) framework in four sequential phases to assess the effectiveness of SIM adoption by providers in the
context of the TASSH TCP implementation strategy in Nigeria.

Public health relevance
Project Narrative Hydroxyurea (HU) is underutilized in low- and middle-income countries (LMIC) like Nigeria due to barriers of adoption at the provider level. Using a mixed-methods implementation design, we will conduct our study in four sequential phases: Based on the Exploration, Preparation, Implementation, and Sustainment (EPIS) framework, and determine the inner organizational context, outer context, and implementation processes likely to influence SIM (Screen, Initiate, and Maintain) adoption of HU by providers at SPARC-NEt clinical sites to improve health outcomes for patients with SCD using the evidence-based TASSH TCP implementation strategy. The findings of this study have the potential to identify effective strategies for improving the management of SCD in Nigeria and other LMIC.